Regulation of Marginal Zone B Cells by NK T Cells

character length restrictions indicate. 1, TITLE OF RESEARCH TRAINING PROPOSAL (Do not exceed 56 characters, including spaces and punctuation.) Regulation of Marginal Zone B Cells by NK T Cells 2. LEVEL OF FELLOWSHIP 3. PROGRAM ANNOUNCEMENT/REQUEST FOR APPLICATIONS Post-doctoral 4a. NAME OF APPLICANT (Last, First, Middle Initial) 4b. EMAIL ADDRESS 4c. HIGHEST DEGREE(S) Franchin, Giovanni [email] MD, PhD, 4d. PRESENT MAILING ADDRESS (Street, City, State, Zip Code) 4e. PERMANENT MAILING ADDRESS (Street, City, State, Zip Code) 1945 Eastchester Road, Apt. 14C Same as 4D Bronx, NY 10461 4f. OFFICE TELEPHONE NO. 4g. HOME TELEPHONE NO. (Area Code, No. and Ext.) (Area Code and No.) 718-430-2664 718-792-0076 4j. [] U.S. CITIZEN OR U.S. NONCITIZEN NATIONAL or 5. TRAINING UNDER PROPOSED AWARD (See Fields of Training) Discipline No.: Subcategory Name: 2200 Autoi mmuni ty 7a. DATES OF PROPOSED AWARD 7B. PROPOSED AWARD 36 4h. PERMANENT PHONE NO. 4i. FAX NUMBER (Area Code and No.) (Area Code and No.) same as 4G 718-430-8711 [] PERMANENT RESIDENT OF U.S. 6. PRIOR AND/OR CURRENT NRSA SUPPORT (Individual or Institutional) [] NO [] YES (If"Yes,"refertoitem24, FormPage 5) DURATION 8. DEGREE SOUGHT DURING PROPOSED AWARD Degree: IExpected Completion Date: N/A I 9c. NIH-DEFINED PHASE SUBJECTS [] NO [] YES SUBJECTS CLINICAL TRIAL [] NO If 'Yes" Exemption No.: ASSURANCE NO. [] YES [] 1la. NAME OF SPONSOR (Last, first, middle initial) Porcelli, Steven A. Telephone: 718-430-3228 FAX: 718-430-8711 Email: porcelli@aecom,yu.edu 1 lc. DEPARTMENT, SERVICE, LABORATORY, OR EQUIVALENT Microbiology and immunology 1ld. MAJOR SUBDIVISION 13, NAME AND TEL. NO. OF ADVISOR IF DIFFERENT FROM 1la. Telephone: Name and address of institution where research training will take place if different from Item 11 b. Address: NO [] YES III 10a.VERTEBRATE ANIMALS 10b.AN1MAL WELFARE ASSURANCE NO. [] NO [] YES A3312-01 11b. NAME OF PROPOSED SPONSORING INSTITUTION Albert Einstein College of Medicine Address:1300 Morris Park Avenue Bronx, NY 10461 12. ENTITY IDENTIFICATION NO. DUNS NO. (ffavailable) 1131624225A2 071036636 14.NAMEOFOFFICIALINBUSINESSOFFICE Mr. Emanuel Genn Telephone:718-430-3182 FAX: 718-430-8822 Title: Assoc. Dean for Bussiness Affairs Address: 1300 Morris Park Avenue Bronx, NY 10461 Email: [email] 15, APPLICANT CERTIFICATION AND ACCEPTANCE: I certify that the statements herein are true, complete, and accurate to the best of my knowledge, and I agree to comply with the terms and conditions of award if an award is issued as a result of this application. I am aware that any false, fictitious, or fraudulent statements or claims may subject me to criminal, civil, or administrative penalties. I certify that I have read the Ruth L. Kirschstein National Research Service Award Assurance, that I will abide by the Assurance if an award is made, and that the award will not support residency training. DATE SIGNATURE (Required of each ap_ _-_...-_,--,_: /._,....._ _,_, ,._